Developmental and nutritional regulation of lipid metabolism

PROJECT SUMMARY
Cells respond to their environment by detecting extracellular signals that dictate how energy resources,
including lipids, are utilized. In complex tissues, cells with specialized metabolic functions perceive
developmental, nutritional, and environmental inputs that strictly control the allocation of lipids into different
metabolic pathways to maintain organismal energy homeostasis. Dysregulation of these pathways can lead to
metabolic diseases or cancer. Pro-growth signal transduction pathways, including the mTOR Complex 2
(mTORC2) and MAP Kinase pathways, promote growth while influencing metabolic decisions; however, the
upstream regulators and downstream effectors of these pathways that control lipid homeostasis remain largely
unknown. We have found that the Hedgehog morphogen, a classic regulator of developmental pattering and
growth, engages mTORC2 signaling to govern lipid homeostasis in C. elegans and mammalian cells. The first
goal of this project is to elucidate the molecular mechanisms that mediate the cross-talk between these two
pro-growth pathways and define how they function together to govern lipid homeostasis. Leveraging the power
of forward genetic screens, we have identified new positive regulators of the Hedgehog-mTORC2 signaling
axis. We will define how these factors promote Hedgehog-mTORC2 cross-talk using interdisciplinary
approaches in C. elegans and mammalian cells. Additionally, we have found that MAPK signaling acts in
concert with mTORC2 in the C. elegans intestine to maintain lipid homeostasis. MAP Kinases, which function
broadly in stress responses and cell proliferation, are crucial for maintaining cellular homeostasis; however,
how MAPK signaling controls lipid metabolism pathways is poorly understood. We found that two MEKK3-like
proteins are required for proper nutrient uptake in the intestine. Using forward genetic approaches, we have
identified candidate downstream effectors of MAPK signaling that control nutrient absorption. The second goal
of this project is to define the mechanism by which MAPK signaling regulates the absorption of nutrients in the
intestine. The long-term objective of these two projects is to uncover new regulatory factors of pro-growth
signal transduction pathways and to elucidate the molecular mechanisms by which they exert metabolic control.
In addition to developmental regulators, cellular metabolism can be shaped by environmental and
nutritional cues that engage pro-growth and nutrient sensing pathways, including the mTOR and AMPK
pathways, to dictate how lipids are utilized. We have demonstrated that acetic-acid producing microbes within
the gut microbiome reconfigure intestinal lipid metabolism pathways to stimulate a fasting-like response in the
host, resulting in loss of fat stores. The third goal of this project is to define the mechanisms by which
metabolites from these gut microbes engage host homeostatic signaling pathways, resulting in reduced lipid
accumulation. Together, this research will shed light on how developmental and nutritional signals interface
with pro-growth and homeostatic signaling pathways to shape the metabolic function of specialized cells.

Public health relevance
PROJECT NARRATIVE Cells respond to their surroundings by perceiving extracellular signals, which trigger intracellular signaling events that shape how energy resources, including lipids, are allocated between fundamental cellular processes. The goal of this project is to elucidate the molecular mechanisms by which pro-growth signaling remodels lipid metabolism pathways to maintain organismal homeostasis. This work will identify new proteins and signaling networks that participate in metabolic regulation, as well as yield mechanistic insight into the underlying causes of a wide range of human metabolic diseases and cancers.